High Resolution Profiling of Senescent Cells in ALS Brain and Spinal Cord

Project Summary/Abstract
Regardless of family history, site of onset, and sequence of symptoms and progression, all Amyotrophic Lateral
Sclerosis (ALS) patients lose muscle mass as the motor neurons that connect to muscle in limbs to control
movement stop working and eventually die. However, there appears to be an extensive delay between initial
neuronal dysfunction and physical degeneration. The complex nervous system is maintained, in part, due to cell
resiliency to stress in order to maintain function and resist activating cell death processes. Experiments in this
proposal will investigate a novel hypothesis: neurons in ALS enter cellular senescence as part of a complicated
stress response to avoid active degeneration and cell death. Nonetheless, while this protective mechanism may
preserve the physical presence of the cell, senescent cell dysfunction and potentially toxic secretome promotes
chronic tissue degeneration over time that facilitates disease progression. Senescence is activated by protein
accumulation in other neurodegenerative diseases. Here we will determine whether TDP43 deposition
differentially affects the cellular senescence stress response by evaluating postmortem human brain and spinal
cord from veteran donors, accessed through the VA ALS Biorepository Brain Bank, with either TDP43 positive
or negative neuropathology. To comprehensively investigate neurons and their environment we will utilize
GeoMx digital spatial profiling technology. This high resolution, high-content non-destructive analytical method
enables the investigation of 100s of proteins at the single cell level while maintaining spatial resolution. This
affords the ability to map the data back to the tissue to correlate protein expression differences with cell
morphology, location in the tissue, extracellular environment and proximity to vascular and / or other pathologies.
The data generated by our research proposal will provided an unprecedented rigor for depth of information on
cellular stress in ALS spinal cord and brain. The rich dataset generated through these experiments will open
many novel avenues of investigation in ALS and potentially unveil cellular senescence as a new therapeutic
target. This is an area desperately in need of development as the majority of ALS patients die, on average, 2-4
years after diagnosis.

Public health relevance
Project Narrative Regardless of family history, site of onset, and sequence of symptoms and progression, all Amyotrophic Lateral Sclerosis (ALS) patients lose muscle function as central nervous system cells stop working and eventually die. This proposal will perform comprehensive analyses on 1000s of individual cells from dozens of central nervous system tissues donated by veterans with ALS. The results will provide an unprecedented depth of information on stresses experienced at the cellular level and how this stress relates to the health of the tissue. Data derived from this project will unveil numerous new directions of research to better understand ALS disease processes with the goal of developing effective therapies.